Linking RNA methylation and TDP43 pathology in ALS/FTD models

PROJECT SUMMARY/ABSTRACT
Amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD) are related neurodegenerative
diseases with few available disease-modifying therapies. In over 95% of individuals with ALS and 50% of
individuals with FTD, affected neurons display cytoplasmic mislocalization and accumulation of transactive
response element DNA/RNA binding protein of 43 kDa (TDP43). TDP43 is an essential regulator of RNA splicing
and stability and is normally localized to the nucleus. As such, pathologic redistribution of TDP43 to the cytoplasm
causes pervasive changes in gene expression, disrupting many integral cellular processes. Accumulating
evidence underscores TDP43’s contribution to ALS/FTD pathogenesis, yet the mechanisms underlying its
mislocalization remain unclear.
We and others determined that TDP43 localization is heavily influenced by its RNA binding. In line with
this, our recent work revealed widespread methylation of TDP43 substrates at the nitrogen-6 position of
adenosine (m6A), a prevalent RNA modification. Physiologically, m6A modifications promote substrate binding
by TDP43. Several TDP43 substrates are abnormally hypermethylated in ALS patient tissues, suggesting a
potential mechanism for RNA dysregulation in disease. Based on these findings, I hypothesize that disease-
associated RNA hypermethylation fundamentally increases RNA binding by TDP43, resulting in its cytoplasmic
mislocalization and subsequent dysfunction. I will test this hypothesis in Aim 1 by examining the relationship
between RNA methylation and TDP43 mislocalization in ALS post-mortem samples and human neuron disease
models. In Aim 2, I will investigate how m6A modulates TDP43’s RNA binding on a site-specific basis. Ultimately,
the goal of this proposal is to elucidate the mechanisms by which m6A modifications impact TDP43 binding,
localization, and function.
These studies may uncover novel mechanisms of neurodegeneration in ALS/FTD and identify potential
therapeutic strategies to restore RNA homeostasis in these diseases. Additionally, the work outlined in this
proposal will provide me the opportunity to develop key skills in experimental design, bioinformatics analysis,
and collaborative research.

Public health relevance
PROJECT NARRATIVE A vast majority of individuals with amyotrophic lateral sclerosis (ALS) and roughly half of individuals with frontotemporal dementia (FTD) display neuronal inclusions rich in the RNA binding protein TDP43. In previous work, we found that (i) TDP43 activity is regulated by RNA methylation at the nitrogen-6 position of adenosine (m6A), the most abundant RNA modification; and (ii) affected tissues display widespread m6A hypermethylation in ALS. Here, I will investigate mechanisms by which RNA methylation modulates TDP43 binding and function, and how this connection may drive TDP43 mislocalization and neurodegeneration in ALS and FTD.